Mechanisms of noncanonical caspase 1 signaling in the brain.

PROJECT SUMMARY/ABSTRACT
This proposal represents a highly innovative research line focused on investigating the interface between
neuroinflammation and serotonin signaling in chronic stress. Chronic stress is a significant risk factor for
many neurological and neuropsychiatric disorders; it induces changes in neural circuitry and behaviors
that may promote maladaptive integration and functioning of brain regions associated with motivated and
emotional behaviors. There has been an increased interest in the association between stress-induced
neuroinflammatory processes and their impact on brain functions. We and others have reported that
Caspase-1 (CASP1) deficiency leads to attenuated stress-induced behaviors of anhedonia and decreased
motivation, with concurrently reduced neuroinflammation, given that CASP1 is the effector molecule of the
inflammasome. We present novel evidence that chronic stress-induced CASP1 activation decreases
glutamatergic neurotransmission in response to serotonin signaling in the nucleus accumbens (NAc),
specifically mediated by the serotonin 1B receptor (5-HT1B), a highly expressed receptor in the NAc.
Chronic stress-induced CASP1 activation leads to serotonin signaling dysfunction. We will test our
hypotheses that the 5-HT1B is a novel substrate for noncanonical CASP1 signaling and that CASP1-
mediated processes play a role in modulating serotonin signaling. We will elucidate molecular and cellular
mechanisms through which CASP1 in the NAc modulates serotonin signaling. This may provide a robust
scientific foundation for understanding the mechanisms underlying maladaptive responses to chronic
stress. We expect our results to provide evidence-based proof-of-principle for the future development of
translational therapeutics targeting canonical and noncanonical neuroinflammatory NAc-based pathways
in stress-induced disorders.

Public health relevance
PROJECT NARRATIVE We present novel evidence that chronic stress-induced inflammasome activation decreases glutamatergic neurotransmission in response to 5-HT1B (serotonin receptor 1B), a receptor that is highly expressed in the nucleus accumbens (NAc). Inflammasome activation triggers caspase 1 activation, and we postulate that 5-HT1B is a novel substrate of noncanonical caspase 1 signaling, which suggests that a caspase 1- mediated process plays a role in modulating serotonin signaling in the NAc. We propose to investigate the relationship between inflammasome activation by chronic stress and serotonin signaling dysfunction.